Admin-Core

Summary Administrative Core (Admin Core)
The Center for Innovation in Point-of-Care Technologies for HIV/AIDS at Northwestern University (C-
THAN) will be a vital partner in the NIBIB Point-of-Care Technologies Research Network (POCTRN). It has the
goal of developing a pipeline of point-of-care technologies critical for improved management of HIV/AIDS
infected individuals in low-and-middle-income countries (LMICs) and facilitating technology commercialization.
The Administrative Core will establish the administrative structure, governance policies, communication plan,
budget management, decision making and conflict resolution processes for the four cores of the center. The
Admin Core will be overseen by the C-THAN Network Steering Committee which consists of the NIH Project
Scientist(s) and the MPIs with equal voting rights. The Network Steering Committee will act as the main
governing board that will review the progress of research activities, develop collaborative protocols, identify
technological impediments to the progress, select strategies to surmount them and identify opportunities for
sharing techniques and tools developed within each individual project. The Scientific Sub-Committee (SSC) of
the Network Steering Committee will actively oversee the Technology Development/Refinement (Technology
Dev), Clinical Translation and Validation (Clinical Trans Valid), the Technology Training and Dissemination
(Technology Train Dis) Cores and projects. We will establish the External Advisory Board consisting of the NIH
Program Officer, external scientific and regulatory experts in biomedical engineering and medicine from the
U.S. and Africa and coordinate administrative efforts between the Network Steering Committee, the Scientific
Sub-Committee, the Technology Dev, the Clinical Trans Valid, and the Technology Train Dis Cores. The output
of the coordinated activities of our center will be a pipeline of products of high clinical impact with strong
commercial potential.